Principles of Speckle-Based Gene Regulation

The cell nucleus houses different types of non-DNA substructures, called nuclear bodies. Among these,
nuclear speckles predominate. Speckles occupy ~15-30% of the nuclear volume and are present in cells
throughout our bodies. Proteins involved in different stages of RNA production are highly concentrated
within speckles, and speckles are the key nuclear body that associates with active euchromatin. How
speckles regulate gene expression has historically been murky due to lack of mechanistic insight. My
past and current research centers on the view that nuclear speckles regulate gene expression in unique
and diverse ways, and that understanding how this works will illuminate disease mechanisms and new
therapeutic paths. My previous work finds two major ways that gene regulation can be impacted by
speckles. First, transcription factors help specific genomic regions localize at speckles, boosting
expression of modestly-sized gene neighborhoods. In the proposed research, we seek to identify new
transcription factors that drive DNA-speckle association, determine the importance of this novel
transcription factor function for cancer biology, and develop ways to inhibit it using covalent ligands. We
apply these objectives to clear cell renal cell carcinoma, neuroblastoma, and macrophage inflammatory
signaling, but hope that the principles uncovered will be applicable across disease states and model
systems. Second, speckles themselves can adopt two major states, altering expression of large gene
neighborhoods. We propose here that this is controlled at the molecular level by factors that link two
structural sub-compartments of the speckle. We also propose that speckle states are highly dynamic and
responsive to extracellular cues via key well-known signaling pathways. We will examine this in cell
culture models and in living animals, testing the hypothesis that the signals secreted after a meal
dynamically regulate speckle form and gene-activating function to coordinate expression of hundreds of
genes within large speckle-associating genomic neighborhoods. In the long term, we anticipate that
understanding how speckles are dynamically regulated will provide new tools that could sensitize tumors
to existing treatments. Over the course of the proposed research, we will integrate imaging, genomic,
bioinformatic, proteomic, and functional approaches to understanding the principles of 1) regulated DNA
positioning at speckles and 2) regulated speckle states. Ultimately, we strive to create textbook models
for speckle-based gene regulation that can then be applied across disease conditions to improve patient
outcomes and quality-of-life.

Public health relevance
Gene regulatory programs are critical drivers of poor outcomes across many disease states, yet the role of nuclear speckles as fundamental drivers of regulatory programs is largely unexplored. By tackling the principles of speckle-based gene regulation, the proposed research opens new therapeutic avenues. Our work has particular implications for clear cell renal cell carcinoma and neuroblastoma, but we anticipate that the principles uncovered can be applied across disease conditions.